Mapping the superficial white matter connectome of the human brain using ultra high resolution multi-contrast diffusion MRI

Abstract
In this 5-year R01 project entitled “Mapping the superficial white matter connectome of the human brain using
ultra high resolution multi-contrast diffusion MRI,” we propose to create the first atlas of the human brain’s
superficial white matter (SWM) using sub-millimeter ultra high resolution diffusion MRI (dMRI). The SWM is
located between the deep white matter and the cortex. It plays an important role in neurodevelopment and aging,
and it has been implicated in a large number of diseases including Alzheimer’s, Huntington’s, epilepsy, autism
spectrum disorder, schizophrenia, and bipolar disorder. Despite its significance in health and disease, the SWM
is vastly underrepresented in current descriptions of the human brain connectome. The SWM contains short, u-
shaped association fiber bundles called u-fibers. Multiple challenges have thus far prevented comprehensive
mapping of the human brain’s SWM. These challenges include the inadequate spatial resolution of dMRI data,
which prevents u-fiber tracing using current tractography methods, as well as the small size, high curvature, and
high inter-subject variability of the u-fibers. An additional challenge is the lack of ground truth information. Our
understanding of human neuroanatomy relies heavily on the results of invasive tracer studies in monkeys, but
the detailed neuroanatomy of the SWM in monkeys has not yet been systematically compiled or analyzed.
We propose to address these challenges to create the most comprehensive description of the SWM to date.
Our strategy includes using ultra high spatial resolution dMRI acquisitions (~700µm isotropic or better) at multiple
echo times (TE), novel dMRI tractography methods designed for tracing u-fibers, anatomically informed machine
learning to parcellate the u-fibers, and expert neuroanatomical generation of the SWM connectivity matrix from
monkey tracer studies. Furthermore, we will develop a novel ontological framework to organize and name the
SWM systems of the monkey and human brains. Overall, these steps will enable robust in-vivo tracing and
capturing of inter-subject variability of the SWM of the human brain at an unprecedented spatial resolution. Our
proposed deliverables will be the first comprehensive, anatomically curated atlases of the SWM in human and
monkey, which will enable the study of the SWM in health and disease. We will publicly release all image data,
tractography atlases, monkey connectivity matrices, extracted fascicles, and all software as open source.

Public health relevance
Narrative The human brain’s superficial white matter (SWM) plays an important role in neurodevelopment and aging and has been implicated in a large number of diseases. Despite its significance, the SWM is vastly underrepresented in current descriptions of the human brain connectome due to multiple challenges that have thus far prevented comprehensive mapping of the SWM. We propose to address these challenges to create the most comprehensive, anatomically curated maps of the SWM to date, which will enable its study in health and disease.